Mali-Guinea Research Leadership Training Program for Sustainable control and elimination of Malaria and Neglected tropical diseases

Project Summary/Abstract
Malaria and neglected tropical diseases (NTDs) remain significant causes of morbidity and mortality throughout
Guinea and Mali, despite substantial progress achieved through implementation at large scale of prevention and
control interventions. The World Health Organization (WHO) set a goal to defeat both malaria and NTDs by 2030.
To achieve this goal, disease control programs face several challenges, including the continuous need to adjust
responses in line with outbreaks and resurgences, changing epidemiological patterns, and development of drug
and insecticide resistance. Operational (OR) and operational and implementation research (OIR) can serve to
evaluate current programs and intervention strategies and adapt evidence-based interventions to meet the evolving
needs of these disease control programs. This research training grant will build upon current training programs to
train the next generation of leadership in OIR to ensure sustained, high performance of the local health systems,
surveillance, monitoring and evaluation and timely scale up efforts of malaria and NTD control interventions.
This renewal application leverages a highly productive public health research training program built over the past
10 years at USTTB, that has enhanced local faculty development, including eight trainees from the initial
cohorts of the program, strengthened the health system with alumni playing leadership roles in the health
system, and continues to train 25 MPH students each year. The training program recently extended to Guinea
and has strengthened south-south collaborations with the development of a similar training program at UGANC
with participation of USTTB Faculty.
The renewal application for a Mali-Guinea Leadership Training Program will provide support for 6 PhD and 8 MPH
students. The program will build a new public health concentration in Implementation Research through
Faculty enrichment and curriculum development, with support from JHU. The program will facilitate a
harmonized training curricula and strengthen mentorship capacity and mutualization at USTTB and UGANC in
order to ensure the sustainability of health services research needs to support malaria and NTD elimination efforts.
A component of this training proposal is collaboration between USTTB, UGANC and JHU faculty and graduate
students; Malian and Guinean faculty and PhD students will travel to JHU, where they will pursue additional training,
and benefit from exchanges with JHU doctoral students and faculty. The program will also support short courses,
workshops, and new diploma courses focused on hands-on OIR, contributing to the efforts of producing a
critical mass of trained public health professional, managers and researchers capable of working closely together
to undertake OIR on malaria and NTDs to refine existing control interventions most efficiently in local contexts.

Public health relevance
Malaria and neglected tropical diseases (NTDs) remain significant causes of morbidity and mortality throughout Guinea and Mali, despite substantial progress achieved through implementation at large scale of prevention and control interventions. Improved in-country expertise in implementation research is critical to address major challenges that limit the translation of high-quality evidence into effective health programs. This Mali-Guinea research training program will strengthen the capacity of doctoral-level public health training programs and professional development to train the next generation of leadership in implementation research to ensure sustained, high performance of the local health systems, surveillance, monitoring and evaluation and timely scale up efforts of malaria and NTD control interventions.